Microvascular mechanisms of growth restriction after environmental toxicant exposure

PARENT GRANT ABSTRACT The uterine circulation and placenta are specifically designed to regulate the flow of blood and transport of essential nutrients to the fetus. Disruption of maternal hemodynamic regulation during pregnancy can adversely impact fetal health, resulting in miscarriage and intrauterine growth restriction (IUGR). Current treatment options for IUGR patients are extremely limited, focusing primarily on early delivery; thus, putting the mother and child at risk for complications associated with preterm birth. Epidemiological studies indicate that pregnant women exposed to fine particulate matter (PM) have a heightened risk of fetal loss and development of IUGR. We have reproduced this phenomenon in laboratory rodent models, wherein animals exposed to nanosized titanium dioxide (nano-TiO2) aerosols develop IUGR and suffer a greater number of `miscarriages' (fetal reabsorptions). We have demonstrated that acute and chronic exposures significantly impair uterine vascular endothelium dependent dilation, severely limiting maternal-to-fetal blood flow and impacting fetal growth. Unfortunately, current research strategies have yet to elucidate the vascular mechanisms associated with the development of IUGR after maternal particulate exposure. Based on previous findings, we hypothesize that maternal inhalation of nano-TiO2 aerosols during pregnancy promotes the development of IUGR by disrupting endothelium- dependent signaling cascades, resulting in a net reduction in uterine vasodilation and blood flow. We further postulate that IUGR will be mitigated by improved vascular signaling and function after nutritional supplementation with folic acid. Using novel approaches and methodologies, these studies will: (1) evaluate uterine nitric oxide-driven vasodilation, (2) determine whether alterations in arachidonic acid metabolism impair uterine vascular reactivity and impact placental perfusion, and (3) assess the therapeutic benefit of dietary folic acid supplementation to improve utero-placental blood flow and attenuate the development of IUGR after maternal exposure to nano-TiO2 aerosols. These studies are conceptually innovative as we will utilize our unique resources to identify mechanistic targets within the utero-placental microcirculation and test directed nutritional interventions for IUGR. This work is technically innovative as we will use novel methodologies developed for the evaluation of environmental toxicity in maternal-fetal medicine. Overall, the successful completion of these studies will: (1) create the conceptual framework to identify environmental exposure as a risk factor for the development of IUGR; (2) reveal new mechanistic insight into the vascular pathogenesis resulting from nanomaterial exposure; (3) provide a molecular basis to identify how nanomaterial exposure manifests as vascular disruptions; and (4) identify mechanistic targets for therapeutic strategies to ameliorate microvascular dysfunction and improve utero-placental blood flow. These interventional strategies are not only limited to PM, but are widely applicable to understanding the role of a spectrum of environmental toxicants in the pathophysiological development of IUGR.

Public health relevance
PROJECT NARRATIVE This is a request to support Ms. Chelsea Cary through the NIEHS Program, “Supplement to Promote Diversity in Health-Related Research” (PA-21-071), under Phoebe Stapleton's (PI) award R01 ES031285. Chelsea is a student in outstanding standing (GPA 4.0) in the Joint Graduate Program in Toxicology (JGPT) at Rutgers University. The studies outlined in this proposal will extend the parent grant to include nanoplastics, which have emerged as environmental toxicants of concern.